Dynamic Metabolic Reprogramming in Macrophages during Immune Response

Project Summary / Abstract
The overarching goal of this project is to understand how cellular metabolism is dynamically reprogrammed in
macrophages during immune responses, and how such metabolic reprogramming impacts immune functions.
Emerging research indicates that metabolism plays a crucial role in supporting and orchestrating immunity.
However, our understanding of macrophage metabolism is just beginning, and is largely limited to static
comparisons of metabolic preferences associated with different activation states. Understanding time-dependent
metabolic rewiring is of great significance because an immune response is a highly dynamic process, through
which macrophages undergo a sequence of functional transitions that mediate the onset and resolution of
inflammation. Proper regulation of macrophage responses is critical, as failure to activate or control macrophage
functions at the appropriate times can lead to a variety of diseases. The integrative approach that we take to
investigate dynamic metabolic rewiring during an immune response starts with a multi-omics characterization
that reveals metabolic processes whose alteration is temporally coupled to functional transitions. This is followed
by targeted perturbations to determine the impact of these metabolic alterations on immune functions. Then we
perform isotopic tracing studies to quantitatively characterize how fluxes through these pathways change during
immune responses and identify important regulatory points. Finally, in-depth molecular studies are used to
elucidate the mechanisms driving these key metabolic alterations and the mechanisms by which such metabolic
alterations orchestrate immune functions. Our preliminary work on the dynamic metabolic rewiring in
macrophages upon LPS and interferon-γ stimulation revealed that alterations in TCA cycle and nucleotide
metabolism are critical for this immune response. We discovered that metabolic fluxes through the TCA cycle
undergo a two-stage remodeling and that inhibition of the pyruvate dehydrogenase complex (PDHC) drives the
transition from early inflammatory stage to late suppressive stage. Building on this, aim 1 will investigate the
molecular mechanism causing PDHC inhibition, and test the hypothesis that PDHC inhibition drives the transition
into a more suppressive state and mediates immune tolerance by restricting acetyl-coA for histone acetylation.
Aim 2 will focus on nucleotide metabolism to quantitatively study how nucleotide synthesis, degradation, and
salvage fluxes change upon LPS and interferon-γ stimulation, and elucidate the mechanism driving such
changes. Aim 3 will expand the scope of this proposal by characterizing the dynamic metabolic reprograming in
response to a variety of other stimuli using multi-omics approaches. It will identify key metabolic transitions in
each response and create a roadmap towards mechanistic understanding of the metabolism-immunity coupling.
Overall, this proposal will elucidate the metabolic underpinnings of immune responses in macrophages, which
has great importance in basic science and broad relevance to diseases where macrophages play a key role.

Public health relevance
Project Narrative Timely and precise regulation of macrophage function is critical for human health. This work will generate novel fundamental knowledge of how macrophage metabolism is dynamically reprogrammed over the course of an immune response, and how this supports and orchestrates dynamic changes in immune functions. It will build a foundation for developing metabolic interventions to modulate macrophage immune responses, which have great potential in treating a wide range of diseases where macrophage function has a central role, including infectious diseases, autoimmune disorders, and chronic inflammatory diseases.